Animal and Human Imaging Shared Resource

CORE 002 – ANIMAL AND HUMAN IMAGING SHARED RESOURCE
PROJECT SUMMARY/ABSTRACT
The Animal and Human Imaging Shared Resource (AHISR) has been continuously supported by the Cancer
Center Support Grant (CCSG) since 2004. The AHISR provides scientific and technical assistance for
experiments employing biomedical imaging for the study of cancer in both the pre-clinical and clinical settings
and continues to undertake developments to meet ongoing needs. As in previous cycles, the AHISR remains a
critical component of VICC’s Specialized Programs of Research Excellence (SPORE) programs, with both
recently renewed Breast and Gastrointestinal (GI) SPOREs having featured imaging components. In 2018, the
AHISR was integral to landing a new NCI-funded co-clinical imaging trial resource (U24) focused on quantitative
PET imaging of cancer metabolism with investigational radiopharmaceuticals. Furthermore, the AHISR expertise
and capabilities have enabled a new partnership between VICC and GE Health Care (GEHC), where quantitative
cancer imaging and radiopharmaceutical discovery are central pillar programs of a major precision oncology
initiative. The faculty and staff within the AHISR provide access to state-of-the-art imaging facilities including
advanced human MRI systems operating at 3T and 7T, a research-dedicated PET/CT, ultrasound scanner, and
a comprehensive facility for multimodal animal imaging and research radiopharmaceuticals for animal and
human use. Furthermore, the AHISR leverages the institutional resources within the Vanderbilt University
Institute of Imaging Science (VUIIS) to develop new and improved methods for obtaining information that
addresses research questions of direct cancer relevance. More specifically, the AHISR will provide:
1. Collaborations with expert imaging science faculty (in nuclear, optical, magnetic resonance and
ultrasound imaging) for the development and application of cutting-edge imaging protocols
2. Innovative and novel radiopharmaceuticals for animal and human imaging research
3. Support for imaging system operators and technical staff who will handle patient and animal preparation
and monitoring as well as operate the instruments
4. Support for data analysis and for quantitative image analysis customized to specific applications including
the co-registration and integration of multiple modalities, histology and proteomics.
The AHISR brings together advanced equipment and diverse expertise into a comprehensive integrated
resource that ensures the quality of the imaging data, and consequently, the overall quality, rigor, and
reproducibility of the studies is the highest possible.

Public health relevance
CORE 002 – ANIMAL AND HUMAN IMAGING SHARED RESOURCE PROJECT NARRATIVE Per the PAR-17-095 FOA, the project narrative is not applicable for the Animal and Human Imaging Shared Resource.